Administrative Core

The success of the PPG is dependent upon effective communication and efficient interactions between project members. This will be greatly facilitated by a centralized Administrative Core at Yale. Moreover, the Core will facilitate paperwork, forms, approvals, and scheduling matters which will increase efficiency and allow PIs to focus more time on their projects. Administrative Core duties will be carried out by an Administrative Assistant (Ms. Amy Ellis) at Yale, under the direction of Dr. David Rothstein (Core Director). The Administrative Core will be responsible for scheduling and coordinating bimonthly audio-visual conferences and lab meetings between the Pi's at Yale and UPMC. In addition the Administrative Core will be responsible for scheduling site visits by UMPC Pi's Drs. Lakkis and Demetris (three times yearly) to Yale and coordinating these with meetings of the internal advisory committee (twice yearly) and with the external advisory committee (once yearly). This will include arranging travel accommodations and reimbursements for the participants of these meetings as well as making conference arrangement. The Administrative Core will also be responsible for the preparation of joint abstracts, manuscripts, and presentations, and progress reports for the PPG. Other responsibilities include accounting and tracking of expenditures as well as the preparation of the annual budgets for the progress reports. Finally, the Core will be responsible of coordinating the shipping of tissue samples to Dr. Jake Demetris (Histopathology Core B) at UPMC. These duties will ensure seamless communications and interactions between the PI's, the Histopathology Core, and promote effective input from advisory committees. Such interactions are key to the collaborative and interactive environment and communications required for ultimate success of the PPG.